Protein Analysis Facility

Protein Analysis Facility Utilization Report PI-Fellow (or staff/student) (Note records are kept by PI and trainee names rather than by project) Tjandra - Strub Tjandra - Bermejo Tjandra - Ma Tjandra - Gruschus Tjandar - Zwolak Tjandra - Suzuki Tjandra - Chen Tjandra - Piszczek Neuman - In Lee - Grimes Lee - Lucas Lee - Pfefferkorn Lee - Jackson Lee - Yap Levine - Kim Levine - Lim Levine - You Levine - Viteri Levine - Allen Levine - Berlett Chock - Sekiya Chock - Kim Chock - Lee Chock - Seo Chock - Wattanasak Korn - Liu Korn - Shu Peterkofsky - Seok Chung - Kang Balaban - Philips Balaban - Pistolesi NIDDK Buchanan - Noinaj FDA Shacter - Luo